Heteroresistance Interdisciplinary Research Unit

ABSTRACT
Antibiotic resistance is one of the most serious medical challenges of our time. This crisis puts patients at risk
of untreatable bacterial infections and threatens major advances of modern medicine that rely on antibiotics
(transplants, chemotherapy, etc). There are at least 2.8 million antibiotic resistant infections each year in the
US, leading to over 35,000 deaths [1]. Without significant action, worldwide annual mortality due to these
infections is predicted to reach 10 million by 2050, surpassing that predicted for cancer [2]. Understanding
resistance mechanisms is critical to designing novel approaches and therapeutics to combat resistant bacteria.
Heteroresistance (HR) is an enigmatic form of antibiotic resistance in which a bacterial isolate harbors a
resistant subpopulation that can rapidly replicate in the presence of an antibiotic, while a susceptible
subpopulation is killed [3, 4]. Not only do many species of bacteria exhibit this form of phenotypic resistance,
but it has been reported against nearly all classes of antibiotics [3, 5, 6]. Unfortunately, our understanding of
HR is extremely limited and its relevance during infection has been unclear. We recently demonstrated that HR
to diverse antibiotics, including the last-line antibiotic colistin, can cause treatment failure in an in vivo model [4,
5, 7]. Furthermore, when the frequency of the resistant subpopulation is very low (<1 in 10,000 cells) HR is
misclassified as susceptible by clinical diagnostic tests, yet is still able to mediate treatment failure [4]. Our
surveillance data reveal that HR to diverse classes of antibiotics is widespread even among highly resistant
carbapenem-resistant Enterobacteriaceae (CRE) and Acinetobacter baumannii (CRAB). Further, we recently
discovered that targeting pan-resistant bacteria with two antibiotics to which a strain exhibits HR reliably leads
to effective combination therapy, highlighting that knowledge of HR can be used to guide effective therapies
[5]. Taken together, these data highlight a largely unappreciated and undetected epidemic of HR in the
clinic that may cause unexplained antibiotic treatment failure but can also be exploited therapeutically.
The Heteroresistance Interdisciplinary Research Unit (HR-IRU) brings together an interdisciplinary team of
experts in an unprecedented effort to understand the mechanisms, dynamics, and prevalence of HR. The
proposed projects, supported by Clinical Isolate and Single-Cell Analysis Cores, will use a combination of
genetics, single cell microscopy, dynamic flow and in vivo infection studies, modeling, and epidemiological
analyses to make foundational insights into HR. At a basic level, this work will significantly broaden our
understanding of how traits exhibited by subpopulations of cells can impact bacterial physiology. At a
translational level, this effort will be a critical step in our fight against antibiotic resistant bacteria and lay the
foundation for the discovery of novel therapeutics, diagnostics, and approaches to alleviate human suffering.

Public health relevance
NARRATIVE Antibiotic resistant bacteria are a growing crisis that not only threaten our ability to treat infections but also advances of modern medicine that rely on antibiotics, such as transplants, chemotherapy and even routine surgeries. Heteroresistance is an underappreciated and emerging form of antibiotic resistance which is poorly understood. The Heteroresistance Interdisciplinary Research Unit (HR-IRU) will elucidate the mechanisms causing heteroresistance, its dynamics and prevalence among clinical isolates, leading to translational interventions to improve human health.